Administrative Core

Abstract
Integrating advanced engineering tools and approaches into immunotherapy development projects holds the
potential to improve the efficiency of the pre-clinical therapy development pipeline. Developing a robust Immuno-
engineering Translation Accelerator (ITA) is a strategic goal for this PPG that stands alongside the scientific
goals of the Projects. The Administrative Core will provide overall leadership and administrative support to this
PPG in furtherance of the PPG’s scientific goals as well as the broader goal to establish a transformational ITA.
The Core will facilitate weekly meetings and semi-annual workshops, promote integration of the PPG projects,
support translational activities that emerge from this PPG, and build a collaborative and innovative cancer
immuno-engineering community at the University of Minnesota. The Administrative Core will be led by MPIs
David Odde (Biomedical Engineer), David Masopust (Cancer Immunologist), and David Largaespada (Genome
Engineer) with support from Paolo Provenzano (Biomedical Engineer), Ingunn Stromness (Cancer
Immunologist), and Branden Moriarity (Genome Engineer). The work of the Administrative Core will be facilitated
by Program Manager Bo Connelly.
To facilitate the broad goals of this PPG, the administrative core will implement the following specific aims:
Aim 1 – Provide strong and consistent leadership and management that maximizes PPG impact.
Aim 2 – Evaluate and facilitate scientific progress.
Aim 3 – Build a collaborative, supportive, and innovative cancer immune bioengineering community.
Aim 4 – Support and accelerate clinical translational through the creation of an Immuno-Engineering Translation
Accelerator (ITA).

Public health relevance
NARRATIVE The Administrative Core will provide overall leadership and administrative support to this PPG. The Core will facilitate weekly meetings and semi-annual workshops, promote integration of the PPG projects, support translational activities that emerge from this PPG, and build a collaborative and innovative cancer immune- engineering community at the University of Minnesota.